Effects of Aging on Cortical Excitability During Motor Learning

The current proposal seeks quantify neural inhibition using magnetic resonance spectroscopy (MRS) and
transcranial magenetic stimulation (TMS) in older Veterans to identify how each measures contributes to
aging-related changes in motor performance. Currently, over 56% (11.8 million) of Veterans are over age 60.
Recent research has shown that aging is associated with decreased cortical inhibition and impaired hand
motor function. However, this loss of inhibition is not an inescapable consequence of aging. Our previous work
that healthy older adults who engage in regular physical activity show increased cortical inhibition and
improved dexterity as compared to their sedentary age cohort. This indicates that aerobic training may reverse
aging related changes in cortical inhibition and alteration of tonic levels of cortical excitability can have a
powerful impact on motor performance in the aging brain. In the current proposal, we will enroll older adults to
assess how different measurements (TMS and MRS) of the dominant inhibitory neurotransmitter in the brain –
GABA differ in relation to motor control. During the MRS scan, participants will perform a motor learning task to
assess change in GABA level throughout the acquisition session. These data will be compared with measures
of cortical inhibition using TMS to quantify neurotransmitter receptor activity with respect to aging-related
changes in motor performance. We will also be comparing the effects of an aerobic exercise intervention as
compared to a contact matched stretching control. We believe this project is the first inquiry of its kind and will
have an important impact in our understanding of aging-related neurophysiological changes in the brain and
how we can remediate associated behavioral declines.

Public health relevance
Over 56% of all US Veterans are over the age of 60. Senescence is associated with loss of inhibitory function within the brain that affects motor control and motor learning. We have shown that aging-related declines in motor performance is linked to decreased levels of intracortical inhibition and impaired motor learning. We propose the current study to investigate the mechanism of this loss of functional inhibition and motor control at the neurotransmitter level. The area of research described in the proposed Merit has strong implications relevant to the rehabilitative needs of Veterans as modulation of cortical inhibition is the direct mechanism by which transcranial stimulation techniques take effect. Yet studies employing these techniques to improve motor control have very varied results due to the fact they are being employed on a brain that is aging. This may be because we are stimulating areas that should be inhibited and vice-versa. Therefore, this study has the potential to lead to efficacious interventions that can translate into improved quality of life for Veterans.